IGF::OT::IGF : TASK ORDER 10. ANALYTICAL SERVICES CENTER FOR MEDICATIONS DEVELOPMENT PROGRAM. SEPTEMBER 15, 2013 - SEPTEMBER 14, 2018. N01DA-13-8920.PURPOSE: TO EXTEND THE PERIOD OF PERFORMANCE FOR

IGF::OT::IGF : TASK ORDER 10. ANALYTICAL SERVICES CENTER FOR MEDICATIONS DEVELOPMENT PROGRAM.